Molecular and structural mechanisms of mTORC1 regulation in cancer

PROJECT SUMMARY
The mechanistic Target of Rapamycin Complex 1 (mTORC1) is master regulator of cell growth and
metabolism. Dysregulation of mTORC1 is observed in sporadic and familial cancers. mTORC1 inhibition
is an established treatment for renal cell carcinoma (RCC). Despite great efforts to target mTORC1 in
cancer, adverse effects limit the use of mTORC1 inhibitors in the clinic. Recent work from our lab and
collaborators has revealed the existence and structural basis of substrate-specific regulatory pathways
that may be targeted with greater precision than heretofore.
mTORC1 is activated on the surface of lysosomes in response to nutrient signals by conversion
of the nucleotide state of the Rag GTPases from inactive (RagA/BGDP-RagC/DGTP) to active (RagA/BGTP-
RagC/DGDP). The Rags are targeted to the lysosome by the Ragulator complex. Rag states are
interconverted by the RagC/D GAP FLCN-FNIP and the RagA/B GAP GATOR1. Subunits of these
complexes, and the Rags, are mutated in cancer. RagA/BGTP and GATOR1 inactivation is required for
phosphorylation of all mTORC1 substrates. RagC/DGDP and FLCN-FNIP activity is only required for
phosphorylation of non-canonical substrates, which include TFEB, the key transcriptional regulator of
lysosome biogenesis and autophagy. Cryo-EM studies of the Rag, Ragulator, and FLCN-FNIP pathway
from our laboratory provided a start-to-finish structural explanation for the repression and reactivation of
FLCN GAP activity in starvation and refeeding. These studies contributed to the discovery that
RagC/DGDP uniquely regulates TFEB and MiT-TFE transcription factors, which in turn explained the tumor
suppressor activity of FLCN in Birt-Hogg-Dubé (BHD) syndrome. This pathway has now been linked to
RHEB activity and Tuberous Sclerosis Complex (TSC). We then demonstrated the existence and
determining the structure and function of the mTORC1-TFEB-Rag-Ragulator “megacomplex”, containing
a full mTORC1 dimer, two copies of TFEB, and four copies of the heptameric complex of active Rags and
Ragulator, showing how RagC/DGDP specifically recruits TFEB.
In aims 1 and 2, we will explore the new avenues opened up the analysis of the megacomplex.
We will determine how the megacomplex is turned over following TFEB phosphorylation, and whether the
principles of substrate specific activation seen for TFEB and RagC also apply to canonical substrates.
Findings will be followed up in BHD and TSC cell lines and a BHD mouse xenograft model. While we now
have a start-to-finish structural mapping of FLCN/RagC/D pathway, the still mysterious regulatory
mechanisms operating in the GATOR1/RagA/B pathway will be elucidated in aim 3, and the cancer
implications explored in knock-out and Glioblastoma cell lines.

Public health relevance
Project Narrative Despite great efforts to target mTORC1 in cancer, adverse effects related to the multiplicity of mTORC1- regulated substrates limit the use of mTORC1 inhibitors in the clinic. Recent cryo-EM work from our lab revealed the structural basis of substrate-specific regulatory pathways that could be targeted with greater precision than heretofore. We will determine how regulation of canonical and non-canonical mTORC1 substrates differs, and reveal the structural basis of mTORC1 regulation by the still largely mysterious mechanisms of the GATOR and KICSTOR complexes.